Functional Analysis of MicroRNAs and Target Genes in Immune Tolerance

Project Summary
Autoreactive B cells play critical roles in many autoimmune diseases. Multiple immune tolerance
checkpoints exist to remove autoreactive B cells or keep them under control. Defects in these checkpoints
constitute the basis for the development of autoimmune diseases. Despite intensive study, our
understanding of these checkpoints remains incomplete and fragmentary. MicroRNAs (miRNAs) are a new
class of small non-coding RNAs that regulate a large diversity of biological processes. Hundreds of miRNAs
are expressed in the immune system. While some miRNAs have been shown to play important roles in
lymphocyte development and function, the roles of miRNAs in controlling immune tolerance remain poorly
understood. We performed in vivo functional analysis of hundreds of miRNAs in the recently established
IgMb-macroself mouse model and identified miR-148a as an important regulator of B cell central tolerance
and autoimmunity (Nature Immunology 17:433-40, 2016). Further molecular analysis identified 119 target
genes regulated by miR-148a in immature B cells. We examined 4 of these target genes and demonstrated
that 3 of them, Gadd45a, Bim and Pten, regulate B cell central tolerance. In this proposal, we will 1) further
investigate the cellular and molecular mechanisms underlying miR-148a regulation of immune tolerance
and autoimmunity, focusing on its role in controlling various B cell tolerance checkpoints and plasma cell
differentiation; 2) evaluate the possibility of treating systemic autoimmunity through miR-148a ablation and
inhibition by genetic and chemical approaches, respectively, and 3) perform an in vitro functional screen of
the other 115 miR-148a target genes to identify novel regulators of B cell tolerance. Our pilot screen has
identified B4galt5 as a positive hit. As B4galt5 is a major enzyme in the glycolipid biosynthesis pathway, we
speculate that this pathway plays important roles in immune tolerance. Therefore, we will elucidate the
function and mechanism of B4galt5 and the glycolipid biosynthesis pathway in controlling B cell tolerance
and autoimmunity.

Public health relevance
Project Narrative Upon the completion of proposed research, we expect to advance our understanding of molecular pathways controlling B cell tolerance checkpoints. Functional analysis of miR-148a and its target genes may reveal an entire network of protein coding genes important for these processes, which may be valuable diagnostic markers and possible therapeutic targets for autoimmune diseases.